Leadership and Administrative Core

LEADERSHIP AND ADMINISTRATIVE CORE ABSTRACT
The Native Elder Research Center (NERC) Resource Center for Minority Aging Research (RCMAR), located at
University of Colorado-Denver and led by Drs. Spero Manson and Dedra Buchwald, has nurtured the next
generation of faculty conducting health research with American Indian and Alaska Native (AI/AN) populations.
Since 1998, 54 NERC Scientists (51 AI/AN) have accrued over $300 million in sponsored research and published
590 articles, and 26 are now tenured faculty. We propose to continue the mission of NERC, submitted by the
Washington State University as a new application that reflects an institutional transition, and expand to include
research with Native Hawaiians and Pacific Islanders. The Community Health and Aging in Native Groups of
Elders (CHANGE) RCMAR will be led by 2 MPIs who each bring unique experiences and strengths to the
program. Dr. Buchwald, MD, NERC Program Director since 1998, is a Professor in Washington State
University’s College of Medicine and Director of the Institute for Research and Education to Advance Community
Health. Julie Baldwin, PhD (Cherokee Nation of Oklahoma), is a Regents’ Professor of Health Sciences and
Director of the Center for Health Equity Research at Northern Arizona University. A renowned Native scientist,
she has 3 decades of experience leading health research with American Indian partners. Together, they will
provide day-to-day and long-term leadership and oversight for all CHANGE components. The Specific Aims of
this Core are to: 1) Support logistical operations, including but not limited to a) monitor adherence to required
institutional, tribal, and federal policies and procedures; b) supervise fiscal activities and budget management;
c) work with the REC to proactively recruit Native and other underrepresented minority early-stage investigators;
and d) facilitate collaboration with the other RCMARs and the RCMAR Coordinating Center; 2) Implement and
monitor activities, including to a) coordinate communication and effort within and between all CHANGE
components; b) compile and disseminate program materials to CHANGE stakeholders; c) conduct program
review and process evaluation to ensure appropriate and high-quality outcomes; and d) generate progress
reports and respond to ad hoc requests from the RCMAR Coordinating Center and NIA; 3) Supervise interactions
with regulatory bodies and sponsors, including to a) formalize agreements with community partners and Pilot
Study participants; b) monitor Pilot Study administration, budgets, and compliance with Institutional Review
Board and tribal review requirements; and c) promote collaboration with other NIH-funded programs and
scientists engaged in aging research; and 4) Embed community outreach and engagement throughout the
Center, including to a) engage with tribal providers and healthcare systems; b) ensure culturally desirable
research topics, methods, and dissemination; and c) encourage CHANGE Scientists to grow relationships with
community partners. NERC has made unparalleled contributions to increasing diversity among investigators
conducting research with and for Native Elders. CHANGE will continue – and accelerate – these achievements.